TRIAL OF TEMOZOLOMIDE IN CHILDREN AND ADOLESCENTS WITH PROGRESSIVE CANCER

This study is designed to test the hypothesis that temozolomide can be safely administered to pediatric and adolescent patients with refractory cancer as a daily oral dose for 5 days. The following specific aims will be addressed in this Phase I study to test this hypothesis: 1)determination of the maximum tolerable dose of temozolomide given orally daily for 5 days; 2) determination of the toxicities of temozolomide given on this schedule; 3) determination of the pharmacokinetic behavior of temozolomide in pediatric and adolescent patients; and 4) determination of the antitumor activity of temozolomide within the confines of a Phase 1 study.